Emergence of somatostatin interneuron function in the developing visual cortex

PROJECT SUMMARY:
GABAergic interneurons are central to the normal development and function of neocortical circuits. In
particular, cells that express the peptide somatostatin (SST-INs) are thought to play critical roles in both
spontaneous and sensory-evoked neuronal activity, primarily via their robust inhibition of the dendrites of
excitatory pyramidal neurons. However, whereas the role of cortical SST-INs in adult animals has been well
characterized, their function in developing cortical circuits is unknown. Indeed, the organization of functional
connectivity of SST-INs at various developmental time points remains unexplored. Our preliminary data suggest
the surprising finding that the circuit-level influence of SST-INs is not yet present at eye opening in juvenile mice,
potentially revealing a critical developmental trajectory for the influence of these interneurons and their
contribution to visual processing. To further explore this observation, we propose to combine a number of
methodological approaches, including juvenile viral injection, advanced behavioral state analysis, optogenetic
manipulations, and 2-photon monitoring of neuronal signaling. We will test the following hypotheses: (1) The
development of the visual response properties of SST-INs directly influences the development of local and large-
scale cortical circuits during the postnatal period. (2) The maturation of these circuits contributes to the
developmental emergence of state-dependent modulation of spontaneous and visually evoked activity in the
visual cortex. Our results will provide an unprecedented level of insight into the development and function of
SST-INs and their relationship to visual processing in the neocortex.

Public health relevance
PROJECT NARRATIVE: GABAergic interneurons play key roles in the development and maintenance of the neocortex. This proposal will determine how interneurons that express somatostatin (SST-INs) contribute to the maturation of circuits underlying spontaneous and sensory-evoked neuronal activity in mouse visual cortex. We expect our findings to provide important insights into the cellular underpinnings of cortical development and visual processing by the brain.